Macromolecular Modeling

The goal of this project is to improve the quality of molecular modeling and molecular dynamics simulations, and to apply these methods to highly pertinent problems, both from the view of biomedical relevance and methodological challenge. In principle, molecular dynamics simulations offer a detailed atomic level description of the interactions between key biomoilecules of significance to human health. In practice, this methodology is limited by the short simulation times (less than 100 nanoseconds) available with current computer technology, which translates into limited conformational sampling, and by the inaccuracies in the empirical force fields used in the simulations. While a number of groups are attempting to relieve the conformational sampling bottlenecks, we are focusing on improvements to the accurracy of representations, without sacrificing computational efficiency. The long range goal is to do simulations from "first principles", i.e. without resorting to empirical fitting procedures. This fiscal year we further developed an efficient algorithm to evaluate interatomic electrostatics using hermite gaussian basis sets, as well as using a cartesian multipole formalism and including the possibility of induced polarizable dipoles. Work on efficient implementation of two existing and one new polarizable, multipolar protein force field is underway.